Measuring and Learning from Care Variation in Sepsis

PROJECT SUMMARY/ABSTRACT
Sepsis is a syndrome of life-threatening organ failure resulting from serious infection that contributes to at least
1.7 million U.S. hospital admissions annually. With mortality of 15-20%, sepsis kills 11 million people each year
around the world. Prompt, appropriate therapy with antibiotics and IV fluids can improve sepsis outcomes, but
many patients with sepsis do not receive optimal therapy. Unwarranted variation in practice between
physicians is an important contributor to this problem. In some areas of treatment, however, practice variation
reflects the fact that the optimal sepsis treatment strategy is not clear. In both situations, the mechanisms
underlying between-physician variation in sepsis care are largely unknown. This research program will apply
advanced epidemiologic, statistical, machine learning, and qualitative research methods to large, granular
clinical datasets to determine how physicians make critical management decisions — including decisions
related to antibiotic initiation, intravenous fluid resuscitation, and emergency department disposition — for
patients with sepsis. A key focus will be understanding how different styles of decision making interact with
different phenotypes of this heterogeneous syndrome to affect patient treatment and outcomes. Investigations
will also harness observed variation to inform causal inference about optimal sepsis management strategies
where current evidence is inadequate. In the process, this research will produce validated, scalable, and
generalizable tools to support high-quality “big data” sepsis research. The proposed research, which is well
matched to the NIGMS sepsis research priorities, will help health systems, researchers, and clinicians design
and deliver sepsis care, provide evidence to build decision support tools customized to patient phenotypes and
clinician decision styles, and lay the groundwork for future trials of sepsis care strategies and implementation
methods.

Public health relevance
PROJECT NARRATIVE Sepsis affects 5-10% of hospitalized patients and kills 11 million people worldwide each year. Prompt treatment improves sepsis outcomes, but optimal antibiotic initiation thresholds, fluid resuscitation practices, and triage strategies are often unclear for individual patients. This research program will investigate how and why different physicians manage patients with sepsis in different ways, helping reduce sepsis morbidity and mortality by generating evidence that will guide selection and delivery of personalized sepsis treatment.